REGULATION OF MUSCARINIC RECEPTORS IN SUBLINGUAL GLANDS

Regulation of muscarinic receptors in rat sublingual glands Current treatment for hyposalivation includes the uses of muscarinic cholinergic agonists. Unfortunately, the currently used drugs are not specific for muscarinic receptor subtypes causing various adverse secondary effects. As more specific drugs are under development, it is crucial to investigate and understand the receptors' behavior upon agonist exposure in order to take advantage of the incoming technology. Unique sequences of 240-375 base pairs for ml, m2, and m3 receptors have been cloned. Each clone was sequenced and verified. From these, RNA probes will be made and used in Northern Blot analysis and in situ hybridization studies to localize ml and m3 receptors in the sublingual gland. M2 will be used as a negative control. After localization of the receptors, functional pharmacological studies will be performed where the receptors will be exposed to various concentrations of the muscarinic agonists at different time intervals. Further, the possibility of receptor sequestration and downregulation upon agonist exposure will be investigated; the mechanisms responsiblefor these events will be defined. The time course for the recovery of receptor expression and function will also be determined.